The Robert H. Lurie Comprehensive Cancer Center

ABSTRACT – OVERALL
The Robert H. Lurie Comprehensive Cancer Center of Northwestern University is an NCI-designated,
comprehensive matrix cancer center conducting a broad range of multidisciplinary clinical, basic, translational
and population science research. The Lurie Cancer Center integrates the expertise and resources of the
Feinberg School of Medicine (Chicago Campus) and its affiliated hospitals along with those of departments
located on the University’s Evanston Campus. The Lurie Cancer Center brings together 271 members from 31
Departments in 4 Schools. Established in 1974, the Lurie Cancer Center has been dedicated to the process of
discovery, advancing medical knowledge and providing compassionate, patient-centered state-of-the-art cancer
care, and conducting community outreach and survivorship programs. This is reflected in the following goals:
1. To conduct and support innovative basic, translational, clinical, and cancer prevention and control focused
cancer research throughout the University.
2. To coordinate and integrate cancer-related activities, including community outreach initiatives.
3. To develop and conduct cancer education programs
4. To promote state-of-the-art cancer care at NU affiliated hospitals and drive precision cancer medicine
initiatives.
These goals are accomplished through the activities of 8 established programs and 14 shared resources:
Over the current CCSG funding period there has been renewed institutional support and investment, new
leadership, and significant growth in all divisions and programs of the LCC. Over the last funding period 88 new
faculty have been recruited, including 30 clinical investigators and 58 laboratory or population scientists. There
has been strengthened clinical and translational leadership and infrastructure and enhanced cancer focus. By
leveraging the new Institutional commitment and support and significant philanthropic resources, the LCC will
continue to develop innovative approaches to reduce the cancer burden in our catchment area and nationwide.

Public health relevance
PROJECT NARRATIVE This Cancer Center Support Grant is requested to provide support for the critical infrastructure and shared resources needed by Lurie Cancer Center investigators to develop approaches and methods for cancer prevention, treatment and control.